Flare assessment for hidradenitis suppurativa

PROJECT SUMMARY
The overarching goal of this proposal is to enhance the quality of clinical trials in hidradenitis
suppurativa (HS) and to improve the current outcome measures for assessing treatment
response by incorporating valid and reliable outcome measures of periodic worsening, or flares,
of HS. This work is significant because it addresses an outcome deemed crucial by HS
researchers and patients; will be the first to develop valid and reliable outcome measures for HS
flare; and generate data on flare frequency and severity from an observational study in order to
inform future study design. This work is innovative because it seeks to refine and expand the
current paradigm for outcome assessment for HS to include flare activity, long-term control, and
minimal disease activity, which are assessed in other chronic inflammatory diseases that
periodically worsen. The overarching goal of this study is to develop, validate, and longitudinally
assess criteria for flare in HS. This project will test the central hypothesis that HS flare can be
validly and reliably measured using patient- and clinician-reported outcome measures. Two
aims are proposed: 1) Validate the patient-reported Hidradenitis Suppurativa Quality of Life
(HiSQOL) insturment for longitudinal HS flare assessment; 2) Validate the clinician-reported
Severity and Area Score for Hidradenitis (SASH) instrument for longitudinal HS flare
assessment. We will address these aims in prospective observational cohort studies
incorporated into a quaternary HS referral clinic with an integrated patient registry where
patients with HS will receive standard of care management. This study will address key gaps in
our knowledge and approach, ultimately leading to effective clinical trials that include outcomes
for HS that change the disease course. We have an established team of investigators with
experience in HS clinical trials and outcome measure development and validation. All of our
data is stored in a robust prospective database, with experience performing the necessary data
entry, data extraction and analysis. The knowledge gained from the proposal will be invaluable
to future clinical trials in HS.

Public health relevance
PROJECT NARRATIVE This prospective observational study will optimize the design of future clinical trials in hidradenitis suppurativa (HS) by providing data on the natural history of flare, or periodic worsening, as well as benchmarking data for patient-reported and clinician-reported outcome measures of HS flare. This project will be crucial to clinical trials because it will provide tools to measure flare and baseline data to inform trial design. The information gained from this study will also serve to educate patients and clinicians about the rate and constituents of a HS flare.